Advancing equity in colorectal cancer genetic risk prediction through expansion of racial/ethnic minority representation

Project Summary / Abstract
As colorectal cancer (CRC) remains one of the leading causes of cancer death new approaches are of vital
importance to make critical inroads in reducing the burden of this lethal disease. Precision medicine holds
enormous promise as advances in genomic research that were previously unimaginable now offer vast
commercial potential and are rapidly being moved into clinical practice, even though critical questions remain to
be addressed. Polygenic risk scores (PRS) that aggregate common genetic risk variants into a single score to
predict disease are a key example. Broad accessibility, plummeting genotyping costs, and the need to account
for the patient's individual risk profile to improve screening have provided transformative opportunities in
personalized prevention. However, wide-scale clinical adoption of PRS raises key ethical and scientific
challenges. Arguably one of the most critical challenge is the fact that current PRS are substantially more
effective in predicting risk in individuals of European ancestry compared with other populations due to the Euro-
centric bias in genetic research. Accordingly, we need to develop an unbiased PRS that predicts CRC risk in all
major racial/ethnic groups. However, this is only the first step towards implementation, which also requires the
evaluation of the optimal risk-stratified screening approach and development of risk communication tool among
others. To address these needs, we will develop and validate an unbiased PRS for CRC across ethnic/racial
minority groups to inform risk-stratified CRC screening (Aim 1a). We will augment the PRS with an environmental/
lifestyle risk score (ERS) to account for other risk factors (Aim 1b) and examine differential effects by age of
onset (Aim 1c), given the alarming increase of early onset CRC. In Aim 2a we will determine the optimal CRC
screening strategy given an individual's risk defined in Aim 1 using our microsimulation modeling by incorporating
differences in CRC incidence and mortality rates by age, sex and race/ethnicity, and in risk factor distributions
across racial/ethnic groups. In Aim 2b we will evaluate the cost-effectiveness of risk stratified screening
compared with current screening guidelines. Finally, we will develop a risk communication tool (Aim 3a) and
investigate potential dissemination issues of risk-stratified CRC screening across ethnic/racial minority groups
(Aim 3b). Our trans-disciplinary research team, which includes a community advisory board, is uniquely set up
to address these critical questions as we 1) have brought together all known racially/ethnically diverse CRC
studies totaling to over 120,000 CRC cases and controls, 2) have strong expertise in developing comprehensive
genetic and environmental risk scores in racially/ethnically diverse populations, 3) lead one of the most
comprehensive decision models for cost-effectiveness analysis which has consistently been used to inform US
screening guidelines and 4) have expertise in implementation science for genetic research in minorities.
Addressing all aims is critical to avoid a sequential science in this rapidly moving field of precision medicine.

Public health relevance
This study will develop a comprehensive risk prediction model based on genetic and environmental/lifestyle risk factors different genetic ancestral population groups. To translate this multi-ancestral risk prediction model into clinical practice, we will use microsimulation modeling to personalize screening recommendations based on genetic and environmental risk factor information and we will develop a web-based risk communication tool which we will evaluate in participants of different genetic ancestry. Results from our study will ensure that targeted personalized interventions will confer similar benefits for all Americans regardless of their genetic ancestry.